Vision, eye growth rhythms and retinal signals in refractive development

Project Summary
The reasons behind the development of myopia and its increasing incidence, particularly among educated
people, remain obscure. The finding that animals can be made myopic or hyperopic by spectacle lenses that
shift the plane of focus to behind the retina (hyperopic defocus) or in front of it (myopic defocus) demonstrates
that refractive development is under homeostatic control. Because the eye can modulate its growth even if the
optic nerve is severed, and because defocus that is restricted to one area only affects the eye growth
underlying that area, it follows that the retina controls eye growth. However, despite two centuries of study,
prophylactic treatments against childhood myopia are limited to atropine drops, contact lenses that reshape the
cornea, or stabilizing treatments for the sclera, all of which have potential side effects and limited efficacy.
Decades of work in our three labs has linked the development of ametropias to alterations in ocular circadian
rhythms. Recently, we showed that the eye’s response to defocus depended on time of day of exposure,
further evidence for the influence of circadian rhythms in myopia development. We also found that 6 clock
genes in retina and choroid were altered in eyes responding to myopic or hyperopic defocus. In this application
we will look for downstream signals of these clock genes using RNA-Seq to determine molecular signaling
pathways that might explain what to target in potential myopia therapies.
How the visual environment affects the growth of the eye and influences refractive error in humans
continues to generate interest, including contemporary studies relating time spent outdoors to the inhibition of
myopia in children, and on the deleterious impact of artificial nighttime lighting on human health in general.
Increasing evidence indicates that exposure to light in the evening, especially short wavelengths, affects sleep
cycles by altering the rhythm in melatonin. We found that a mere 2 hours of blue evening light stimulated
ocular growth and altered ocular rhythms. This application will address the influences of time of day, relative
spectral composition and the dopamine and melatonin rhythm on the responses to brief blue light. We will
study the role of the ipRGCs, and the potential interaction between hyperopic defocus and blue light. These
studies will have implications for the use of light-emitting technologies prior to bed.
Our finding that six clock gene transcripts, and melanopsin, showed diurnal cycling in choroid suggests
diverse circadian functions for this tissue. We aim to study circadian signaling in choroid, with focus on roles
of dopamine and melanopsin. We will localize melanopsin, and in an exploratory series of experiments, we will
ask if the rhythm in choroidal thickness is endogenous to the choroid, and address the hypothesis that the
choroid is photosensitive. We will use chicks, a species with rapid and well-characterized compensatory
responses to visual manipulations, and retinal/visual similarities to humans. We expect that this work will
generate novel and useful hypotheses that can be extended to the study of refractive errors in children.

Public health relevance
Project Narrative The prevalence of myopia is increasing world-wide in developed regions and the complications of myopia are leading causes of blindness. Daily rhythms influence the refraction of the developing eye, and we hypothesize that altered ocular circadian rhythms driven by the retinal clock play a role in the development of myopia. Understanding how attributes of the visual environment and their timing during the day affect ocular growth rates, and the molecular basis of these influences, will clarify the signaling cascade between retina and sclera that produces myopia. This knowledge is crucial to understanding the mechanisms of myopia and to identify much-needed, effective approaches to normalize refractive development in children.